NATIONAL CHILDREN'S STUDY: VANGUARD STUDY (SOUTH ROC)

To provide data collection, data processing, retention and outreach for a NCS Regional Operations Center To provide data collection, data processing, retention and outreach for a Regional Operations Center of the NCS Vanguard Study.